Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
Strategic planning and evaluation at the Laura and Isaac Perlmutter Cancer Center (PCC) occur in a regular, systematic manner across all mission areas to ensure a consistent and uniform vision and advance our mission. PCC Senior Leadership aims to attract and retain the best and brightest scientists, clinicians, and staff members, who share a common goal of advancing the fields of cancer outreach, research, education, and patient care, and to ensure consistent and regular evaluation of all scientific programs, shared resources, and cores. Since the last CCSG review, PCC Senior leadership has been overhauled significantly, with several new Associate Directors and Program Leaders who brought talent, experience, and direction to the task of crafting and implementing our new Strategic Plan. We also made some changes and additions to our External Advisory Board and established an Internal Advisory Board, while engaging continuously in self- examination and evaluation via a set of well-defined, regularly scheduled committee meetings. The Specific Aims of Leadership, Planning, and Evaluation are: 1) to oversee and implement a rigorous strategic planning process, 2) to recruit and retain experienced, and collaborative Senior leaders, 3) to ensure consistent and regular evaluation of all Research Programs, Shared Resources, and Cores by Internal and External Advisory Boards, and 4) to organize meetings symposia, retreats, and conferences that facilitate review and exploration of future strategic directions.